Evaluation of Dependence and Nicotine Replacement Therapy-Supported Cessation Efforts among Regular Electronic Cigarette Users

Project Summary. Electronic cigarette (ECIG) use has increased in the U.S. since ECIGs were introduced to
the market in 2006. While ECIG use among adults was originally most common among current cigarette
smokers, in recent years there has been an increase in the prevalence of ECIG use among individuals who
have never been established cigarette smokers as well as former cigarette smokers who have transitioned to
ECIG use. Little is known about this population of non-smoking ECIG users, including if they experience
unique indicators of ECIG dependence. However, most ECIG dependence assessments rely on self-report
measures that were developed from those originally designed to measure cigarette smoking dependence.
These measures may not capture indicators of dependence that are unique to ECIG use and more relevant to
ECIG users who are not current cigarette smokers. Additionally, as ECIG use among non-current smokers has
increased, so has the interest in ECIG cessation among this population. Best practices have been developed
to support cigarette smoking cessation including the use of combination nicotine replacement therapy (NRT)
products, such as the nicotine patch and lozenge. Given that the primary addictive substance in ECIGs is
nicotine, NRT has the potential to be an effective tool for ECIG cessation. Yet the ability of NRT to support
ECIG cessation, which has been evaluated in only two pilot studies, remains unclear. Moreover, this pilot work
relied on user self-reports to measure ECIG abstinence. Indeed, objective methods to verify ECIG use
behaviors and abstinence during cessation attempts are urgently needed. One such method may be
measuring ECIG liquid weights across days to represent the amount of liquid consumed. Another method may
be the measurement of propylene glycol (PG), a primary component of ECIG liquid that has been
demonstrated to be detected and quantified in users’ urine. This project aims to examine 1) indicators of
dependence that are unique to ECIG use, 2) the impact of NRT on short-term ECIG cessation attempts, and 3)
novel methods for verifying ECIG use behaviors and short-term ECIG abstinence. Data from this project will
increase understanding of ECIG dependence, including indicators that may be unique to ECIG use relative to
cigarette smoking and are not captured in current measures of ECIG dependence. This project will also
provide important data on how NRT may support ECIG cessation among non-current smokers as well as an
evaluation of several approaches that can be used to verify ECIG use behaviors and abstinence beyond user
self-report, both of which are valuable for development of best practices for supporting ECIG cessation. Thus,
successful completion of this project will support efforts to prevent negative health outcomes associated with
ECIG dependence and use.

Public health relevance
Project Narrative. Electronic cigarette (ECIG) use among people who are not current smokers has increased; however, little is known regarding unique indicators of dependence among this population or the best approaches to support ECIG cessation among those who are interested in quitting vaping. The proposed study will examine 1) indicators of dependence that are unique to ECIG use, 2) the impact of nicotine replacement therapy on short-term ECIG cessation attempts, and 3) novel methods for verifying ECIG use behaviors and short-term ECIG abstinence. This study can inform understanding of ECIG dependence and development of best practices to support ECIG cessation.